A quality control pipeline for enhancing reproducibility of immunology studies with shared data

PROJECT SUMMARY
The parent project of this administrative supplement application is the NIAID U19-funded Maternal
Immunization and Determinants of Infant Immunity (MADI) program. MADI is a multidisciplinary investigation of
immunity during pregnancy and the factors linking maternal immune status to child health. MADI has brought
together diverse investigators with powerful human subjects cohorts contributing rich clinical,
sociodemographic, and high-throughput data sets. The MADI Data Management and Biostatistics Core has
designed, built and implemented a custom data management platform to support MADI’s immunological
research in accordance with FAIR data management principles. Our Interactive Serology Plate Inspector (I-
SPI) software is a robust quality control (QC) pipeline for multiplexed bead array assay (MBAA) data
compatible with the MADI Data Portal and NIAID’s ImmPort repository. We aim to: expand the I-SPI tool to
other assay types commonly found in ImmPort by implementing and enhancing existing QC methods for other
data types; collaborate with ImmPort to expand the ImmPort data model to hold these quality-related metadata;
put data already in ImmPort through our QC pipelines to extract quality-related metadata and populate the new
aspects of the data model, adding value to the ImmPort resource by enhancing its alignment with FAIR
principles and promoting its reproducibility and replicability.

Public health relevance
PROJECT NARRATIVE The Maternal Immunization and Determinants of Infant Immunity (MADI) program aims to understand the maternal factors governing immune response during pregnancy and early life. The MADI Data Management and Biostatistics Core has previously developed a quality control pipeline for multiplex bead array assay data. With this supplement funding, the Core aims to expand this software to support other assay types and to collaborate with the NIAID-funded ImmPort repository to store quality-related metadata for a selection of its existing data sets.